Integrated Demographic and Health Survey Data for Population Health Research

PROJECT SUMMARY/ABSTRACT
The NICHD-funded IPUMS Demographic and Health Surveys (IPUMS DHS) project vastly simplifies
comparative health analyses, democratizing research by providing free, easy-to-use data for researchers of all
skill and resource levels. IPUMS DHS is an ideal tool for climate change and health (CCH) research because it
includes data on many climate-related health outcomes important to NICHD. To date, however, it has focused
on health rather than climate change. Only eight percent of the research listed in the IPUMS DHS bibliography
addresses CCH, revealing the immense untapped potential for new research that can be unleashed with
supplemental funding. This supplement leverages IPUMS DHS to achieve the full promise of CCH research
with the following aims:
● Supplemental Aim 1. Extend IPUMS DHS to enable CCH research on malaria. IPUMS DHS includes
standard DHS surveys, but it does not yet include the DHS Malaria Incidence Surveys (MIS) that include
most information on malaria, a major killer of children and a disease highly susceptible to weather conditions.
To extend CCH research to malaria, we will incorporate DHS MIS data into IPUMS DHS.
● Supplemental Aim 2. Empower users to flexibly link climate data with IPUMS DHS variables and
increase climate-relevant variables in IPUMS DHS. We will disseminate GPS coordinates so users can
link their own geospatial, climate, and meteorological variables to IPUMS DHS microdata and create
summary variables, such as Minimum Dietary Diversity, important for understanding causal pathways
between climate change and health.
● Supplemental Aim 3. Create a Climate Change and Health Launchpad website with robust support
tools for rigorous and reproducible CCH research using IPUMS DHS. To ensure IPUMS DHS is fully
and appropriately exploited for CCH research, we will create a website with accessible instructional tools,
including foundational videos, tutorials, comprehensive guides, and model open-source code with detailed
instructions for study-specific modifications.
This supplement will greatly enhance the power of IPUMS DHS for CCH research by providing a powerful set of
new variables designed to illuminate pathways between climate change and health and robust technical support
tools for groundbreaking research by analysts from across the globe.

Public health relevance
NARRATIVE We will create a new focus on climate change and health (CCH) research within IPUMS DHS, which is a rich source of comparable health data for low and middle-income countries. We will extend health-outcome coverage to malaria, facilitate linkage of the health data with climate data, add new summary variables, and provide online resources to guide CCH research. Transnational and cross-temporal research on CCH based on IPUMS DHS data will help researchers identify health problems related to climate change, reduce health inequities, and mitigate the effects of climate change.